Elucidating pathways underlying the association of contraception use with ovarian cancers through metabolic profiling

PROJECT SUMMARY/ABSTRACT
The overarching goal of this project is to comprehensively quantify changes in metabolites and pathways
(collectively, the metabolomic profile) associated with oral contraception (OC) use to elucidate mechanisms
involved in ovarian and breast carcinogenesis. Ovarian cancer (OvCa) is the 5th most common cause of cancer
death among females, but risk is 15-30% lower among women who have ever used OCs. Conversely,
epidemiologic studies also show modest but significant increased risk of breast cancer (BrCa), the most common
cancer of US women, with OC use. One approach for disentangling the effects of OCs on cancer risk and
elucidating etiology is the integration of metabolomics into epidemiologic research. Recent studies support
circulating plasma metabolites and metabolite groups are associated with OvCa and BrCa, and that OCs can
change metabolomic profiles. However, key barriers to determining the mechanisms of OC use that contribute
to cancer risk include: 1) limited details of OC use in large cohorts (e.g. formulation, duration, age at first use),
2) inadequate consideration of individual variability in physiologic response to OC use (e.g. metabolizing enzyme
activity, endometriosis (OvCa risk factor), family history of OvCa/BrCa), and 3) lack of biospecimens representing
the local environment relative to the cancer site of origin (e.g. peritoneal cavity for OvCa). Dr. Mongiovi will
address these limitations in an assessment of metabolites associated with OC use using a machine learning and
systems biology approach. Leveraging data from the Nurses’ Health Studies (NHS, NHSII) and the Women’s
Health Study: From Adolescence to Adulthood (A2A), Aim 1 (K99) will identify circulating metabolomic profiles
of current OC use among premenopausal women and prior OC use among postmenopausal women and
evaluate differences by genetic variants in hormone biosynthesis and metabolism pathways, endometriosis
status, and family history. Metabolite profile scores of current and prior OC use will be developed and the
association of each metabolite score with risk of OvCa and BrCa will be determined in nested case-control
studies within NHS/NHSII. Aim 2 (R00) will characterize local metabolomic profiles relative to the development
of BrCa in normal breast tissue from then Komen Tissue Bank, OvCa using previously collected peritoneal fluid
from A2A participants, and novel assessment of vaginal fluid among women recruited from local clinics. The
proposed research will elucidate how OCs alter OvCa and BrCa risk by comprehensively assessing systemic
and local metabolomic profiles. By disentangling the processes through which OC leads to reduced OvCa and
increased BrCa risk through metabolomic profiling, we can improve risk prediction and identify targets for
prevention and interception. During the K99 phase, Dr. Mongiovi will follow a well-rounded training plan in support
of these aims developing proficiency in analysis and interpretation of omics data and cultivating expertise in
ovarian and breast tumorigenesis. This K99/R00 award will support her in obtaining the knowledge and
experience to effectively pursue a career as an independent, interdisciplinary researcher in female cancers.

Public health relevance
PROJECT NARRATIVE The proposed project aims to comprehensively quantify changes in systemic and local metabolites and pathways (collectively, the metabolomic profile) associated with oral contraception (OC) use that relate to ovarian and breast carcinogenesis. The circulating metabolomic profile will be evaluated using details of OC use, such as formulation, timing, and duration, and examined at the local level relative to the development of breast (normal tissue) ovarian tumors (peritoneal and vaginal fluids). Results from the proposed study will elucidate the biological pathways altered by exposure to OCs that lead to ovarian and breast cancer risk and may ultimately inform on novel targets for cancer prevention and interception.